Chaperoning Preassembly Modules for Mitochondrial Ribosome Assembly

Henry, Michael F.
Abstract
The goal of the proposed research is to define the mechanisms of ribosome assembly within
mitochondria. While remarkable progress has recently been made towards understanding the structure of
mitoribosomes, the unique pathways and factors that facilitate their biogenesis remains largely unknown.
Dysfunctional mitoribosome assembly abolishes the synthesis of several essential components of the
respiratory chain, which can compromise cellular energy production and generate reactive oxygen species
that promote degenerative disease, aging, and cancer. Thus, a clearer understanding of how these
highly complex macromolecular structures are assembled is necessary to better understand mitochondrial
disease. To gain insight into this process, this proposal will examine how an evolutionarily conserved yeast
protein called Mam33 effectively chaperones a subset of newly imported mitoribosomal proteins and
facilitates their incorporation into the assembling large subunit. This mitoribosomal chaperone contrasts
with those in bacterial and eukaryotic assembly pathways because it binds multiple mitochondrial
ribosomal proteins (MRPs), rather than a single ribosomal protein. This and emerging data suggest that
mitochondria might minimize the complexity of ribosome biogenesis by forming small RNA-free
preassembly blocs complexed with Mam33, rather than the individual addition of MRPs observed for
bacterial and eukaryotic cytosolic ribosomes. The first aim will determine the composition and binding
characteristics of Mam33-MRP preassembly complexes. These experiments will determine 1) the number
and composition of the preassembly complexes, 2) their binding domains and 3) whether they can form
without Mam33. This information will advance our understanding of Mam33 function and mitochondrial
ribosome assembly chaperones in general. The second aim will assess the binding properties of Mam33-
MRP preassembly complexes. These experiments will 1) establish whether Mam33 targets the N-terminal
regions of its mtLSU client proteins, 2) delineate the docking sites for its 5 known mtLSU cargo proteins, 3)
identify potential new interactants and 4) examine Mam33-client protein incorporation at a specific mtLSU
assembly step. Since Mam33 is conserved in eukaryotic organisms, information gained in yeast will be
applicable to human disorders. In human patients, bi-allelic mutations in its ortholog p32/HABP1/gC1qR
cause severe multisystemic defects in mitochondrial energy metabolism, which directly result from
oxidative phosphorylation deficiencies and mitochondrial instability. Furthermore, p32 overexpression
has been detected in nearly all tissue specific forms of cancer and associated with poor prognosis. For
these reasons, understanding the physiological role of this protein in the mitochondrion is timely.

Public health relevance
Henry, Michael F. Project Narrative This proposed research seeks to better understand the causes of mitochondrial disorders; a group of diverse diseases that includes cancer, infertility, diabetes, heart disease, blindness, deafness and neurodegenerative diseases. The yeast model organism will be used to study a feature of mitochondrial genome expression conserved in humans. This information is necessary for discovering the underlying causes of mitochondrial disorders and may help identify potential therapies that could prevent, or even reverse, mitochondrial diseases.